Novel applications and translation of [18F]hGTS13, a system xc- specific radiopharmaceutical

ABSTRACT.
Ferroptosis is a form of regulated cell death defined by the iron-dependent accumulation of membrane lipid
peroxides that results in oxidative damage and plasma membrane disruption. Ferroptosis is a form of cell death
that is mechanistically and morphologically distinct from other forms of cell death, such as necroptosis, apoptosis,
and pyroptosis. Targeting ferroptosis has garnered immense interest in the cancer research community owing
to the potential to selectively active this mechanism of cell death in cancer cells. To realize the full potential of
inducing ferroptosis in cancer, non-invasive imaging markers are needed.
System xc-, the cystine-glutamate antiporter, is a plasma membrane transporter mediating the cellular uptake of
cystine in exchange for intracellular glutamate. System xc- plays a critical role in ferroptosis by regulating the
availability of cystine, a crucial precursor for glutathione biosynthesis, thus impacting the cellular antioxidant
defense system and ultimately influencing susceptibility to ferroptosis. Modulation of system xc- activity with
pharmacological inhibitors is a potential therapeutic strategy that regulates this form of cell death in anti-cancer
therapy. Molecular imaging of system xc- therefore has the potential to identify cancers with appropriate
transporter activity that would be suitable for ferroptosis induction, assess drug engagement and inhibition of
system xc- in living subjects, and monitor the efficacy of targeting this emerging mechanism of cell death in
cancer. To the best of our knowledge, the investigation of system xc- radiopharmaceuticals in this context of
ferroptosis, has yet to be reported.
We have pioneered the development of [18F]hGTS13, a homo-glutamate radiotracer specific for system xc-.
Importantly, [18F]hGTS13 demonstrates several advantages over existing system xc- radiotracers including: 1)
incorporation of a UV-active group, thus greatly facilitating radiosynthesis and quality control; 2) improved
transporter specificity; and 3) reduced uptake in multiple immune cell types and improved cancer specificity. The
goals of this proposal are to establish [18F]hGTS13 PET as a non-invasive imaging marker of drug induced
cancer ferroptosis in cell culture and pre-clinical models and to clinically translate [18F]hGTS13 by determining
its pharmacokinetics in healthy human volunteers through an exploratory investigational new drug mechanism.
We will first establish the relationship between [18F]hGTS13 uptake and sensitivity to cancer ferroptosis in the in
vitro and in vivo setting (SA1). We will then test the ability of [18F]hGTS13 to monitor the engagement of pro-
ferroptotic drugs in vivo and predict treatment response (SA2). Lastly, we will translate [18F]hGTS13 for first-in-
human testing and determine its biodistribution and radiation dosimetry in healthy volunteers (SA3).
Successful completion of this project will establish the foundation for employing [18F]hGTS13 to select patients
that are likely to be sensitive to ferroptosis inducing therapies and monitor treatment effects. The findings from
this work will have high impact as inducers of ferroptosis advance to clinical investigation.

Public health relevance
PROJECT NARRATIVE. Ferroptosis is a form of regulated cell death that is characterized by the accumulation of lipid peroxides, leading to oxidative damage, plasma membrane disruption, and cell death. Ferroptosis is partly mediated by the amino acid transporter, system xc-, owing to the critical role of system xc- in regulating cellular antioxidant defenses and redox balance. This proposal will test the hypothesis that [18F]hGTS13, a system xc- specific radiotracer, can inform on the sensitivity of different cancers to ferroptosis and monitor pharmacological induction of ferroptosis, additionally, we will translate [18F]hGTS13 for first-in-human investigation.